Temporal lobe epileptogenesis

Project Summary / Abstract
Our ultimate goal is to discover causes of seizures in patients with temporal lobe epilepsy. The primary
objective of the proposed project is to generate new data on reelin-positive interneurons in the dentate gyrus
and test whether their loss is epileptogenic. The specific aims are to: Identify the type of reelin interneuron
whose loss correlates with seizure frequency. Test whether loss of reelin interneurons in the dentate gyrus
occurs in a large animal model of temporal lobe epilepsy. Test whether reelin-positive interneurons are total
molecular layer cells. Measure the strength of synaptic output of reelin interneurons. And test whether loss of
reelin causes seizures. To achieve these goals animal models will be evaluated: pilocarpine-treated rats and
sea lions with naturally occurring temporal lobe epilepsy. Methods employed will include continuous telemetric
video-EEG seizure monitoring, immunocytochemistry, stereology, whole cell recording in hippocampal slices,
biocytin labeling, paired recording of unitary inhibitory postsynaptic currents, and prolonged focal brain infusion
using mini-osmotic pumps.

Public health relevance
Project Narrative One in 26 people in the United States develops epilepsy, temporal lobe epilepsy is one of the most common types, and current treatments fail for approximately 1/3rd of patients. The proposed project would test whether the loss of a specific type of inhibitory brain cell causes seizures in patients. Knowledge of causes of seizures will lead to better treatments.